I: Penn State Institutional Career Development Core

PROJECT SUMMARY/ABSTRACT-PENN STATE INSTITUTIONAL CAREER DEVELOPMENT CORE
Advances in the efficiency, quality and impact of clinical and translational science (CTS) research will be
achieved by researchers who are trained in rigorous research methodologies and equipped to navigate a
pathway from basic discovery to improved health. The overall goal of the Penn State Clinical and Translational
Science lnstitute's (CTSI) Institutional Career Development Program is to accelerate scholar transition to
research independence. Our priorities include increasing the racial, ethnic, and scientific diversity of our scholars,
utilizing innovative strategies to engage and guide scholars to enhance research productivity, extending
engagement in rural health research, and refining our data-driven continuous programmatic improvement. We
will recruit KL2 scholars with outstanding potential to become catalysts for innovation in biomedical research
translation. In this application we request support for 4 KL2 scholars and have an institutional commitment
for an additional 4 scholars. All grant-funded and institutionally funded scholars will be selected through a
University-wide RFA, have access to the same career development opportunities, and same expectations for
progress toward development of scientific independence. The selected scholars will be enrolled in an intensive
3-year program designed to prepare the next generation of leaders in CTS. Our Aims are to:
1. Recruit and engage talented scholars from diverse backgrounds in collaborative clinical and
translational sciences (CTS) career development.
2. Implement an intensive mentoring/coaching strategy for current and recent scholars to "turn the
curve" on scholar transition to independence.
3. Leverage the strengths of our CTSl's rural environment, partnerships and technologies to develop a
CTS research practicum in rural health.
4. Refine processes for collection, analysis and utilization of evaluative data guided by the logic model
to foster continuous quality improvement of the career development program.
We recognize multiple factors contribute to the scholars' transition to independence, including their initiative,
persistence, resilience, supportive mentorship, interactions with collaborators, protected research time, and the
institutional research infrastructure and culture. Timing for milestones on the path toward independence also
varies depending on each individual's prior training. Our programmatic offerings are coordinated with the
Translational Endeavors Core, the Community Engaged Research Core (CERC) and the TL 1 program, and
include advanced degrees, core seminars, experiential opportunities, individual courses, learning modules, and
flexibility for individualized learning. Intended outcomes are competent translational researchers with skills to
accelerate discovery by bridging gaps and innovation along the translational research continuum.